Elucidating the consequences of dietary sugar consumption on the gut microbiota

Project Summary
The gut microbiota is a critical determinant of human health and development. Diets rich in the refined sugars
glucose and fructose can modulate gut microbial abundance and metabolism thereby increasing disease
susceptibility. However, the mechanisms governing microbial responses to dietary sugar in the gut remain poorly
understood. We have demonstrated that host dietary sugar consumption silences expression of a colonization
factor called Roc in Bacteroides thetaiotaomicron, an abundant gut bacterium associated with lean, healthy
individuals. We determined that a conserved transcription factor is necessary to synthesize Roc and regulates
additional bacterial factors that mediate critical host-microbial interactions, including an immunomodulatory
protein and fucose utilization genes. We hypothesize that the activity of this transcription factor is governed by a
putative intracellular metabolite that is differentially synthesized according to host diet composition and
dramatically reduced upon sugar-rich diet consumption. We have identified critical molecular players governing
the activity of this transcription factor and propose to 1.) elucidate the mechanisms governing its activation, 2.)
determine how dietary sugar consumption silences its activity, and 3.) characterize the consequences of host
sugar-rich diet consumption on microbial product synthesis in vivo. We believe that this work will reveal a
conserved pathway that is disrupted by host sugar consumption resulting in aberrant gut microbial activities.
Furthermore, this work has uncovered a molecular target for modulation of microbial abundance and metabolism
in the host and can be exploited for rational manipulation of the gut microbiota to treat diseases.

Public health relevance
Project Narrative Sugar-rich diets can promote disease by modifying gene expression and metabolism in the human gut microbiota. We are investigating how dietary sugar consumption silences the activity of a highly conserved bacterial transcription factor necessary for gut colonization. We have identified molecular determinants that control the activity of this transcription factor and propose to elucidate how host sugar consumption reduces its activity in vivo. Our study will reveal how modern industrialized diets influence the human gut microbiota and identify novel molecular targets to manipulate gut microbial composition and metabolism.